Core D: Long-Term Follow-Up

PROJECT SUMMARY/ABSTRACT
This Core supports Projects 2 and 3 by collecting long-term follow-up data for patients who have undergone
hematopoietic cell transplantation (HCT) or cellular immunotherapy (IMTX) at the Fred Hutchinson Cancer
Center (FHCC), University of Washington (UW) or Seattle Children’s Hospital (SCH) under protocols developed
at the FHCC. The services of this core unit address several closely related areas: identification and management
of late complications, data and research sample collection, database assembly and evaluation of the efficiency,
accuracy, quality and utility of the data collection and the system in which the data are stored. We have
developed several mechanisms to support this overall goal.
1. We will collect long-term data focused on survival, therapy-related complications, and health relevant to
the clinical research studies supported by this grant. This includes the prospective cohort of patients to
be studied in Projects 2 and 3 of this grant application who require follow-up for at least 15 years after
treatment. For this purpose, a system has been established to track and maintain contact with patients
and referring physicians so that data can be collected at specified time points after treatment.
2. We will assist investigators in obtaining information and research biospecimens that are not routinely
collected but are needed for individual research projects.
3. We will continue to identify barriers that interfere with long-term follow-up of geographically dispersed
patients and develop methods to overcome these barriers.
4. We will continue to evaluate the research methods employed in data collection and database
management, including the efficiency, reliability, validity and utility of the instruments used for data
collection.
The data generated from this core unit will assist project leaders in understanding the long-term efficacy of
experimental treatments and identifying late complications and mechanisms of relapse after cellular therapy with
HCT or targeted T cell therapies. Close coordination with the clinical Long-Term Follow-Up Program (LTFU) that
provides telemedicine services ensures prompt notification of clinical events such as relapse. Integrating long-
term data collection efforts across the Projects through Core D provides efficient services to support this
Research Program.

Public health relevance
PROJECT NARRATIVE The Long-Term Follow-Up Unit (LTFU, Core D) supports the Program by providing extended data collection and biospecimen acquisition services to the Projects. Through a combination of chart review, annual surveys and active contact with participants and providers, Core D is responsible for ensuring that protocol requirements beyond the acute treatment phase (generally 2-3 months) are performed and research samples are collected. Core D also interacts closely with Core B, which is responsible for early data collection and all data analysis.